Upstream pathogenesis in familial and sporadic frontotemporal dementia and motor neuron disease

Frontotemporal dementia (FTD) and motor neuron disease (MND) are progressive neurodegenerative
disorders linked to TDP-43 pathobiology. Little is known about upstream pathogenesis, especially in
sporadic disease. The overarching model we seek to test in this R01 renewal is that genetic and sporadic
forms of FTD/MND-TDP converge upstream of TDP-43 mislocalization and aggregation. To evaluate this
hypothesis, we will study post-mortem brain tissue from patients with C9orf72-associated and sporadic
FTLD/MND-TDP, mining a unique dataset assembled during the previous cycle using a novel multiplexed
immunofluorescence platform. In Aims 1-2, we will deeply characterize the interaction between C9orf72-
associated dipeptide repeat protein inclusions and TDP-43 and seek evidence for TDP-43 inclusions with
similar characteristics in sporadic FTD/MND. In Aim 3, we will use biochemical and proteomic methods
to seek novel dipeptide repeat protein and TDP-43 interaction partners, leveraging a rare cohort of
patients with C9orf72-FTD/MND who show profound behavioral deficits despite minimal TDP-43
pathology and comparing them to patients with a high TDP-43 aggregate burden. In all aims, we will seek
to correlate quantitative neuropathological variables with clinical symptom severity, functional status, and
neurodegeneration severity. Collectively, these human tissue-based studies are expected to clarify the
disease-relevance of emerging candidate upstream pathogenic events and to uncover and validate novel
features using complementary tissue-based and bioinformatic approaches. This fundamental information
has the potential to identify new therapeutic targets for evaluation in other experimental systems or in
human clinical trials.

Public health relevance
This project seeks new insights into upstream pathogenesis in frontotemporal dementia and motor neuron disease. We will pursue this goal using a novel multiplexed immunofluorescence platform, advanced histological methods, and proteomic approaches. If successful, this research could lead to better treatments for patients with frontotemporal dementia and motor neuron disease and could change the way neuropathological studies are used to understand disease pathogenesis.